NC State Chemistry of Life Training Program (CLTP)

Project Summary
Training in the application of chemical principles is essential for modern research across a number of disciplines
ranging from Chemistry and Biochemistry to Biology, Engineering and Medicine. Acknowledging this need, NC
State University has launched a new research and training program called the Chemistry of Life Program (CLP)
and initiated an innovative graduate training program, the Chemistry of Life Training Program (CLTP), as a core
element. A key aspect of this program is core training, both lecture and experimental, in core chemical biology
principles and techniques. This not only facilitates completion of the students’ dissertation research, but also
lays the basis for career opportunities in academic, government, and industrial research settings. To achieve
this, the CLTP has partnered with the Comparative Medicine Institute and Biotechnology Training Program to
synergize this program across our campus though at least 4 Colleges and 7 Departments. A trans-departmental
Executive Committee will lead the operation of the CLTP and oversee sub-committees focusing on program
elements. The specific objectives of the training program are: 1) Ensure technical proficiency and training in
responsible and rigorous science; 2) Provide an educational and training experience that is in line with graduate
students’ expectations for an interdisciplinary future; and, 3) Nurture robust PhD graduation outcomes. Six slots
(three in year 1) are requested that will be augmented by four slots (two in year 1) from University resources.
The program requirements include a minor in the Chemistry of Life; a course in professional development/
scientific rigor and reproducibility; courses in research ethics; and an annual research symposium/retreat. These
requirements are in addition to those associated with the student’s particular Department or Program for the
doctoral degree. During their two-year appointment to the training grant, trainees will also benefit from an
exploratory laboratory rotation program, co-mentorship across disciplines, access to development workshops on
topics like research commercialization, and the opportunity to be guided through mentorship of undergraduate
researchers on a team science project. This program will also provide a central focus for faculty of the various
disciplines involved in this training effort to seek out new opportunities for formal and informal research
collaboration as part of the broader CLP program.

Public health relevance
Project Narrative The complex biomedical research questions of today require scientists to have both specialized expertise in their field and also the skills to bridge that expertise across fields in a team science environment; however, most graduate training focuses exclusively on the development of specialized expertise. The interface between chemistry and biology is one of the most common and important intersections of fields, playing a key role in everything from basic fundamental discoveries to advanced pharmaceutical development. The Chemistry of Life Training Program will complement NC State’s existing doctoral programs in in the molecular sciences, by providing trainees with the technical skills, mentorship, and professional development needed to cross the Chemistry: Biology interface, producing a new generation of scientists prepared to tackle the most complex biomedical issues.